Characterization of interferon epsilon mediated protection against Trichomonas vaginalis and its suppression by parasite extracellular vesicles

PROJECT SUMMARY / ABSTRACT
Trichomonas vaginalis (Tv) the causative agent of trichomoniasis is the most common non-viral sexually
transmitted infection (STI) with approximately 150 million new people infected annually. The continued
emergence of drug resistant strains of Tv, and an emerging appreciation of the link between asymptomatic Tv
infections with inflammation-driven pathologies and negative effects on reproductive health demands better
understanding of this prevalent human infection. Clinically relevant infection most commonly occurs in female
reproductive tract (FRT) where it must contend with the unique mucosal immune environment of the FRT. Thus,
understanding how Tv subverts the host cell immune response, with a particular focus on the unique immune
environment of the FRT, will be key in attempts to prevent pathogenesis by the parasite. Extracellular vesicles
secreted by Tv (TvEVs) are now appreciated as one way the parasite can alter pathogenesis. The central
hypothesis of this proposal is that TvEVs play a major role in suppressing host cell immune responses that would
otherwise impede parasite-mediated host cell lysis a process critical for the acquisition of nutrients by this
obligate extracellular parasite. To test this, I will leverage preliminary transcriptomic data showing that TvEVs
down-regulate expression of a non-canonical, type I interferon, IFNε and in vitro assays showing that
pretreatment of prostate and vaginal epithelial cells with IFNε is protective against Tv-mediated killing. In Aim 1,
I will characterize the mechanism by which IFNε protects host cells from Tv-mediated cytolysis. In Aim 2, I will
determine the mechanism by which TvEVs disrupt the type I IFN pathway. In addition to these aims, I have
established a career development strategy that supports my research goals through a rigorous schedule of
scientific communication workshops and trainings on grant writing, laboratory management, and laboratory
mentorship. These activities are designed to help me successfully transition from my postdoctoral position to an
independent researcher studying the unique immune response of the FRT to Tv.

Public health relevance
PROJECT NARRATIVE Trichomonas vaginalis is an extracellular protozoan parasite and a common sexually transmitted infection with an unusually high detection rate in older women. The proposed study aims to elucidate how T. vaginalis subverts immune responses of the female reproductive tract to establish pathogenesis to inform therapeutic interventions.